Mechanisms for generative vision in the primate ventral stream

Abstract
Visual input is full of noise and ambiguity, thus the brain needs to actively infer the most likely interpretation from
multiple possible causes. Remarkably, even though this process of inference relies on billions of neurons
distributed across the entire visual hierarchy, what we consciously perceive is always coherent, e.g., if we see a
face in an electrical outlet, then we also see two eyes and a mouth. A powerful idea to explain this coordinated
inference process is the “analysis by synthesis” paradigm, which posits that the visual system successfully
perceives a scene when it can simulate how it is generated. “Synthesis” refers to the top-down reconstruction of
an image from a higher-level proposal, and perception is successful when the reconstructed image matches the
incoming sensory input. According to analysis by synthesis, visual perception is always coherent because it is
synthesized to be so; specifically, via hierarchical generative feedback, a change in interpretation at the highest
level can coherently steer representations across all earlier levels. In this proposal, we seek to understand
whether and how analysis by synthesis is implemented by the primate ventral stream. The project constitutes a
close collaboration between an expert in macaque ventral steam electrophysiology (Tsao) and an expert in
dynamical systems modeling (Engel). We propose to use Neuropixels probes to record simultaneously from
multiple nodes of the macaque face patch network, an experimentally tractable model for the primate ventral
stream. Furthermore, we will develop novel flexible and interpretable computational models for identifying
dynamics of neural representations with millisecond resolution on single trials from high-dimensional neural
activity data. We will investigate two scenarios where generative feedback should be especially important:
perception of ambiguous images (Aim 1) and perception of degraded images (Aim 2). Finally, in an exploratory
Aim 3, we propose to record from multiple face patches while monkeys sleep, to look for signatures of generative
visual feedback during dreaming. The project will give unprecedented insight into the dynamic computations
underlying hierarchical visual inference.

Public health relevance
This project seeks to understand how different brain areas work together so that animals can experience coherent interpretations of visual scenes despite noise, ambiguity, and even complete absence of sensory input during dreaming. The work will capitalize on state-of-the-art techniques in neuronal recording and computational modeling to understand fundamental principles about how hierarchically organized brain areas work together to construct our perception of the visual world. Since many neuropsychiatric disorders, including schizophrenia and autism, involve a deficit in interpreting the outside world, the results of our experiments will have significant health relevance with respect to understanding coordinated brain function.